Identifying therapeutic pathways targeting medulloblastoma-immune cell interactions

SUMMARY
We propose developing a systems-biology approach to understand interactions between tumor and immune
cells and their clinical implications. Our work will focus on medulloblastoma, a malignant pediatric brain tumor
in which our team has extensive expertise. We and others have shown that medulloblastoma tumors are sites
of immune activity despite the blood-brain barrier. However, the clinical consequences of these immune cells
are unclear and there is little information that might guide development of therapeutics that modulate these
immune cells.
Our innovative strategy combines single-cell methods, including single-cell proteomics, with a sophisticated
computational analysis. In Aim 1, we map the landscape of tumor-immune interactions using sequencing and
imaging methods on human samples. Aim 2 builds a causal model of the molecular interactions that govern
interactions among cell types in medulloblastoma, determines the clinical correlates of these cells, and
identifies potential therapeutic targets. Aim 3 maps the tumor-immune environment in well-validated mouse
models of the disease, and builds computational models for mice parallel to those for humans. Hypotheses
from Aim 2 that are likely to translate well to the mouse models are then tested for their effects on tumor
growth and survival. The mouse results are used to update the computational models and refine the
therapeutic strategies. We expect that successful completion of this project will have a substantial impact on
medulloblastoma therapeutics. Further, the methods we develop will catalyze research of interactions between
immune cells and many other tumor types beyond medulloblastoma.

Public health relevance
NARRATIVE Medulloblastomas are one of the most common pediatric brain tumors, and they have not benefited from recent dramatic advances in treating cancer by activating the immune system. Our study proposes developing a detailed molecular and cellular understanding of how these tumors interact with the immune system. Through computational modeling of these data, we will seek approaches that could alter the immune system to benefit medulloblastoma patients.